Molecular Basis of Pathogenicity of IgA1-containing Immune Complexes

Abstract
IgA nephropathy (IgAN) is the most common form of primary glomerulonephritis in the world. Due to lack of
disease-specific therapy, many patients progress to end-stage renal disease. IgAN is defined by the
characteristic IgA1 mesangial deposits. Based on our published data, we have developed an original
pathogenesis model that describes sequential steps and molecular candidates for the development of disease.
This model is recognized by other researchers in the field as a blueprint for development of disease-specific
biomarkers and treatments. In the past funding period, we demonstrated that the majority of IgAN patients,
regardless of age and ethnicity, have immunologic defects resulting in generation of pathogenic IgA1-
containing immune complexes. We have further shown that the pathogenic immune complexes consist of IgA1
with some O-glycans deficient in galactose (Gd-IgA1), although Gd-IgA1 alone is not sufficient to induce IgAN.
A second critical step in the pathogenesis of IgAN is the development of autoantibodies that bind Gd-IgA1 and
form pathogenic immune complexes. Our new data revealed that IgG extracted from glomerular deposits of
IgAN patients is specific for Gd-IgA1. Importantly, serum levels of Gd-IgA1 (autoantigen) and IgG
autoantibodies specific for Gd-IgA1 each correlate with disease severity and progression. Our analyses also
revealed the presence of complement proteins in Gd-IgA1-IgG circulating immune complexes. This finding is
consistent with our GWAS that identified a major role for a common deletion of the complement factor H-
related factors 1 and 3 (CFHR 1,3 del) that impacts C3 activation. We have identified major activation
pathways induced by Gd-IgA1-IgG complexes in primary human mesangial cells and shown that blockade of
the initial signaling steps prevented aberrant cellular activation. Moreover, we have begun to validate these
findings in a novel mouse model of IgAN we developed. In this revised competing renewal application, we
hypothesize that, in individuals with an autoimmune predisposition, elevated Gd-IgA1 is associated with the
development of IgG autoantibodies specific for Gd-IgA1. These events direct the formation of pathogenic
immune complexes and additional proteins modulate the pathogenic potential of these complexes, thus
affecting disease presentation and progression. We will follow-up our findings using unique, clinically and
genetically well-characterized, cohorts of IgAN patients. We will define the biological and clinical impact of IgG
autoantibodies, including the timeline for production before disease onset (Aim 1). We will assess the
composition of Gd-IgA1-IgG immune complexes in the circulation vs. in the glomerular deposits (IgG
subclasses, complement proteins) (Aim 2) and determine the role of complement in biological activity of the
pathogenic Gd-IgA1-IgG complexes (Aim 3). Relevance: Our studies will define factors associated with
development and progression of IgAN and thus provide information concerning stratification of patients for
clinical trials and development of a future disease-specific therapy.

Public health relevance
Narrative IgA nephropathy is the most common form of primary glomerulonephritis in the world, with many patients progressing to end-stage renal disease, as there is no disease-specific treatment. We propose to define the biological and clinical impact of IgG autoantibodies and other proteins associated with pathogenic immune complexes that lead to the development and progression of disease. The results of the proposed experimental and clinical studies will provide a basis for the development of noninvasive tests for the detection of disease activity prior to irreversible kidney damage and suggest disease-specific therapeutic strategies. 1